Clonal hematopoiesis and accelerated metabolic dysfunction in obesity

ABSTRACT
The accumulation of somatic DNA mutations over time is a hallmark of aging in many tissues. However, the
causal role of somatic mutations in age-associated disorders other than cancer is a matter of debate, and
remains unexplored in the setting of metabolic disease. Recent large exome sequencing studies in humans
have shown that aging is inevitably associated with an increased frequency of somatic mutations in the
hematopoietic system, which provide a competitive growth advantage to the mutant cell and thus allow its
clonal expansion (clonal hematopoiesis). Unexpectedly, these somatic mutations were associated with a
higher rates of cardio-metabolic disease, suggesting a previously unrecognized link between somatic
mutations in bone marrow-derived cells and these disease processes. However, whether there is a
causal connection between these somatic mutations and metabolic dysfunction remains unclear and the
potential underlying mechanisms are unknown, and this is the scientific premise of the proposed research.

Public health relevance
NARRATIVE The accumulation of somatic DNA mutations over time is a hallmark of aging in many tissues. However, the causal role of somatic mutations in age-associated disorders other than cancer is a matter of debate, and remains unexplored in the setting of metabolic disease. The proposed research seeks to determine if there is a causal connection between a relatively common somatic mutation in the hematopoietic system and metabolic dysfunction, and to ascertain the potential underlying mechanisms.